NATIONAL PEDIATRIC CRITICAL CARE CONTROL REG. AND STAT. CENTER

The Systems Manager continues to be involved in supporting and developing the PCCSGNet Software for this long term computer-only project.